Structure and Function of Virulence Factors of Bacillus anthracis

Detailed structural analyses of the anthrax toxin proteins by our group and others continues to offer opportunities to engineer the proteins as tools for cell biology and as the basis of vaccines and therapeutics. Our prior work has provided robust methods for production and purification of the anthrax toxin proteins: protective antigen, lethal factor, and edema factor. A large number of substitution and fusion proteins have been constructed to facilitate analysis and exploitation of these proteins. We previously arranged through the NIH technology transfer office for many of these proteins to be distributed by Kerafast. Their website lists more than 10 of our protein variants that are available to researchers wishing to evaluate their utility. Kerafast also continues to distribute the unique S9.6 monoclonal antibody that recognizes DNA/RNA hybrids. In the current year of 2016, this antibody remained extremely popular, being sold to hundreds of researchers. It is typically used for studying the normal and pathological roles of DNA/RNA hybrids. Transcriptional start sites typically have a region in which nascent mRNA is bound to one DNA strand, displacing the opposite DNA strand, producing what is termed an R-loop. Determining the location and abundance of R-loops provides important information regarding translational processes. During 2016, we supported the NIH technology transfer office in licensing this antibody to EMB/Millipore as an additional distributor. For future work with S9.6, we are developing methods for production of a single chain (scFv) version of the antibody. This protein will also be used by others to obtain crystal structures of the antibody bound to a DNA/RNA hybrid. Our studies on protein expression and characterization have been extended during 2016 to additional proteins produced by various pathogens. A number of expression systems have been developed for production of the mycobacterial proteins ESAT6 and Ag85b. These are being engineered with modifications that will allow them to be used as vaccine candidates and immune modulators. During 2016 we studied the structural properties and biological roles of the small Bacillus anthracis Hfq proteins. Hfq proteins in Gram-negative bacteria play important roles in bacterial physiology and virulence, mediated by binding of the Hfq hexamer to small RNAs and/or mRNAs to post-transcriptionally regulate gene expression. However, the physiological role of Hfqs in Gram-positive bacteria is less clear. B. anthracis, the causative agent of anthrax, uniquely expresses three distinct Hfq proteins, two from the chromosome (Hfq1, Hfq2) and one from its pXO1 virulence plasmid (Hfq3). The protein sequences of Hfq1 and 3 are evolutionarily distinct from those of Hfq2 and of Hfqs found in other Bacilli. We produced each of these three proteins in Escherichia coli. While Hfq2 adopts the expected hexamer structure, Hfq1 does not form similarly stable hexamers in vitro. The impact on the monomer-hexamer equilibrium of varying Hfq C-terminal tail length and other sequence differences among the Hfqs was examined, and a sequence region of the Hfq proteins that was involved in hexamer formation was identified. It was found that, in addition to the distinct higher-order structures of the Hfq homologs, they give rise to different phenotypes. Hfq1 has a disruptive effect on the function of E. coli Hfq in vivo, while Hfq3 expression at high levels is toxic to E. coli but also partially complements Hfq function in E. coli. These results set the stage for future studies of the roles of these proteins in B. anthracis physiology and for the identification of sequence determinants of phenotypic complementation.